2025 Rachmiel Levine-Arthur Riggs Diabetes Research Symposium

PROJECT SUMMARY
2025 Rachmiel Levine-Arthur Riggs Diabetes Research Symposium
November 14-17, 2025, Westin Pasadena, Pasadena, CA
Despite the significant knowledge obtained and the progress made in the treatment of diabetes over the last 50
years since the discovery of insulin, translation of this understanding to the clinic, and implementation of
acceptable standards of care for diabetics has been suboptimal. In view of the rapidly growing worldwide
diabetes epidemic - the disease affected 22.3 million people in the USA and 371 million people worldwide in
2012, and is expected to double by 2030 if current trends hold - it is imperative to enhance current interactions
among investigators. This is to foster new collaborations, and pool knowledge and resources so that the cellular
and molecular mechanisms responsible for the disease and its complications can be determined, and novel
therapeutic strategies developed that will effectively prevent, delay, and even cure diabetes.
The 2025 Rachmiel Levine-Arthur Riggs Diabetes Research Symposium, to be held from November 14-17, 2025
at The Westin in Pasadena, California, will continue to meet the growing demand to keep researchers, clinicians
and trainees abreast of the latest developments in diabetes- and endocrine-related research. The Symposium
is organized by the City of Hope’s Arthur Riggs Diabetes and Metabolism Research Institute (AR-DMRI) and is
expected to attract over 250 attendees from both the U.S. and abroad with diverse academic backgrounds
including, endocrinologists, diabetologists, islet biologists, stem cell and gene transfer scientists, transplant
scientists, immunologists, cell biologists, young investigators in all these areas, and health care professionals
who manage individuals with diabetes. The four-day meeting will offer presentations from over 60 experts in the
field of type 1 diabetes and islet cell biology. The meeting will consist of introductory lectures and plenary
sessions that will each conclude with a panel discussion. In addition, the meeting will offer a debate session, oral
presentations from junior investigators and trainees, and a poster session for both junior and established
investigators to present new and exciting data. The Symposium provides an important venue for investigators
to present their data to an audience of national and international experts, helping to foster the career growth of
junior investigators.

Public health relevance
PROJECT NARRATIVE 2025 Rachmiel Levine-Arthur Riggs Diabetes Research Symposium November 14-17, 2025, Westin Pasadena, Pasadena, CA The 2025 Rachmiel Levine-Arthur Riggs Diabetes Research Symposium will continue to offer investigators a state-of-the-art, comprehensive scientific forum of international caliber and scope by covering topics in diabetes- and endocrine-related research. The Symposium has represented an invaluable source of knowledge sharing for the scientific and medical communities involved in type 1 diabetes research and care, and it will continue to promote new interactions and collaborations among junior investigators and established leaders in the future.